Transdermal Mechanical Loading for Cell Therapy-Based Bone Repair

Cell therapy for bone repair combined with hydrogels, networks of crosslinked polymer chains with very high
water content, is gaining in acceptance as a potential alternative to scaffold-based tissue engineering,
especially for smaller scale defects that may be treatable through minimally invasive methods. Injecting cells
into a bony defect with a small incision may be preferable to more invasive surgical procedures when clinically
indicated. Once at the defect site the cells are left largely unperturbed within the hydrogel as the defect itself
would require stabilization to permit healing, a requirement that goes against the therapeutic benefit of
physically loading bone forming cells. It is this contradiction that has driven the work outlined in this proposal.
Non-invasive, low-intensity pulsed ultrasound has been shown to be effective for transdermal treatment of
fresh fractures (38% reduction in clinical and radiographic healing time) and fracture nonunions. While the
mechanism through which LIPUS acts is poorly understood we have developed a highly tunable ultrasound
system that demonstrates a measurable acoustic radiation force at clinically relevant ultrasound intensities and
have shown this force to be capable of physically deflecting both cells and hydrogels. However, to date
LIPUS-generated acoustic radiation force has not been paired with cell-loaded hydrogels for bone repair.
The goal of this proposal is to combine LIPUS-generated acoustic radiation force and hydrogel-based cell
therapy with the belief that both approaches together will enhance repair over either one alone. Using LIPUS-
generated loading capable of imparting physical forces on cells, it is our intention to design hydrogel scaffolds
that 1) are able to deliver encapsulated viable cells in vivo, 2) can be physically loaded by LIPUS generated
acoustic radiation force after implantation and during the healing process and 3) can be modified to transfer
varied physical forces from the hydrogel to cells such that healing would be optimized.
The objectives of the present research are 1) to evaluate the effect of LIPUS-generated acoustic radiation
force on cells embedded in hydrogels with increasing crosslinking densities, 2) to evaluate the effect of
radiation force on cells encapsulated in collagen hydrogels of varying mechanical properties to determine the
relationship between applied force and hydrogel stiffness on cell behavior, and 3) to use radiation force applied
to hydrogels that have been loaded with cells and implanted in bone defect models. Implanted hydrogels
containing cells will be loaded transdermally using acoustic radiation force. It is anticipated that the
parameters defined in the in vitro studies will result in enhanced in vivo defect healing in hydrogels under
acoustic radiation force when compared to either parameter alone.

Public health relevance
Narrative The PI's laboratory has focused on the development of tissue engineering strategies for bone repair using polymer and polymer/ceramic composite scaffolds and integrating hydrogel-based cell therapies with acoustic radiation force to repair bone defects. To achieve these goals, the PI has collaborated with clinicians, cell biologists, molecular biologists, materials scientists and engineers both at the University of Connecticut and outside Universities as well. The work proposed in this application will provide a novel strategy for healing bony defects through the use of cell therapies and transcutaneous acoustic radiation force.